Training Program/Rheumatic Diseases

Project Summary
The Training Program in Rheumatic Diseases is now completing a remarkable 5 years in its current inception
training new scientists in the investigation of the pathophysiology, diagnosis, treatment, and outcomes of
rheumatic diseases. The Program is a collaborative effort between the Adult and Pediatric Divisions of
Rheumatology at The University Pennsylvania and The Children’s Hospital of Philadelphia along with The
University of Pennsylvania Biomedical Graduate Studies program, and the Graduate Medical Education
programs of the Adult and Pediatric Rheumatology Divisions. The Program offers a rich environment for
mentored training in basic laboratory investigation, translational research, clinical epidemiology, and
bioinformatics, and spans immunology, muscle and bone biology, and clinical rheumatology. Our multi-
disciplinary cohort of trainers come from the Perelman School of Medicine and the School of Veterinary Medicine
and represent multiple Departments and Divisions. In recognition of the rapid expansion of technology and
methodology that blurs lines between bench and clinical research, the Program has emphasized adding mentors
and trainees in bioinformatics, translational science, and other domains to best position ourselves to continue
our success in the development of the future scientific leaders in Rheumatology. Post-doctoral trainees are
selected from the already highly competitive and select pool of clinical fellows from both the Adult and Pediatric
Rheumatology fellowship programs, as well as PhD scientists within the participating Schools investigating
aspects of rheumatic disease. Typical appointments are for 2 years, pending appropriate progress by the trainee.
Given that our pipeline of meritorious trainees is outstripping current availably in the program, we request to
expand this award to support 6 post-doctoral positions. Since the inception of the current T32 award, both the
Adult and Pediatric fellowship training programs added and filled additional ACGME-accredited slots, reflecting
our ability to attract increasing numbers of talented and qualified trainees eager to take advantage of our unique
training and research environment. All trainees benefit from an exceptional set of colloquia, seminars, retreats,
and lectures, and trainees are expected to contribute to this environment through their own presentations and
publications. Once each trainee’s mentoring team is formed, an Individualized Development Plan is created that
is regularly reviewed and revised by the trainee, mentor(s), and PIs of this Program, including assessment of the
trainees’ and mentor’s performances. The Program itself is continuously evaluated by direct feedback from
trainees and mentors, through annual review by an Internal Advisory Board and an external consultant, and by
self-assessment techniques. As a measure of success, in the past 5 years, this Program trained multiple
investigators running their own foundation/NIH-funded mentored research programs in Rheumatic Disease and
others that are clearly on track to independence upon completing their training.

Public health relevance
Project Narrative The Penn/CHOP Training Program in Rheumatic Diseases will continue to provide the infrastructure and outstanding opportunities required to develop the next generation of physicians and scientists prepared to address the need to close our knowledge gaps about basic pathophysiology, diagnosis, epidemiology, outcomes, and treatment of rheumatic diseases in all their manifestations. The program’s goal is to provide a rich, multi- disciplinary, multi-modal training environment to support the success of developing trainees toward becoming independent scientists dedicated to research in Rheumatic Disease. This program builds upon many decades of success by the Penn/CHOP Adult and Pediatric Rheumatology Divisions in training leading researchers in Rheumatology and this program’s outstanding achievements during its initial cycle of funding.